Animal Model Production Section

PROJECT SUMMARY ANIMAL MODEL PRODUCTION CORE
The overall goal of the Somatic Cell Editing Consortium (SCGE) is to create a novel, integrated set of genome
editing tools to accelerate translation of these approaches to the clinic. The goal of the JAX Gene Editing
Mouse Testing Center (JAX-GEMTC) is to provide a robust, scalable platform for the optimization and
credentialing of new editing machinery. Reporter models designed to detect different types of specific and non-
specific genome-editing activity are essential for the systematic and efficient evaluation of a variety of novel
delivery approaches designed to target a diverse array of disease-relevant cells and tissues. The specific goals
of the Animal Model Production component of this Center are to generate and validate a suite of genome-
editing reporter mouse lines that will illustrate the efficiency, specificity, and nature of editing modifications with
single-cell resolution, and to develop a platform for future reporter line development to serve the goals of
SCGE consortium members. Building on our existing reporter model, we will create a panel of reporter lines
that support analysis of multiple editors, editing outcomes, and off-target activity. Through the colony
management and distribution effort of the RESOURCE CORE, these models will serve to support the goals of
the TESTING CORE. Our goals will be achieved through three Specific Aims: 1) We will generate mouse
reporter lines designed to test somatic cell editing efficiency and specificity for multiple types of editing activity,
including NHEJ-mediated indels, HR, base editing, and off-target activity; We will assess the function of each
reporter line in vivo to assure its utility as a test platform for new delivery technologies; 3) To develop and
deploy platforms and models to support future collaborations with the SCGE consortium. To accomplish this,
we will validate and implement a novel recombinase-mediated cassette exchange (RMCE) platform to improve
the efficiency of targeting of large reporter constructs, and will work with the SCGE to develop reporter models
that assess novel editor functions not captured by the panel of lines produced in Aim 1.